Multi-modal Health Information Technology Innovations for Precision Management of Glaucoma

PROJECT SUMMARY/ABSTRACT
Glaucoma is the world's leading cause of irreversible blindness. Early detection and treatment
are critical, as symptoms typically do not present until the disease is advanced. A data-driven
precision medicine approach is needed to better identify individuals who are at greatest risk of
developing the disease and who are at greatest risk of progressing quickly to vision loss. While
there has been considerable progress in eye imaging and testing to improve glaucoma
monitoring, precision management of glaucoma is incomplete without accounting for patients'
co-existing systemic conditions, concurrent systemic medications and treatments, and
adherence with prescribed glaucoma treatment. These factors are important for providing a
more comprehensive perspective of glaucoma management and for improving patient
outcomes, yet they are relatively understudied.
In the parent award, I am applying multi-modal advancements in health information technology
(IT) to address these gaps and achieve the following specific aims: (1) Develop machine
learning-based predictive models classifying patients at risk for glaucoma progression using
systemic electronic health record (EHR) data from a diverse nationwide patient cohort (the NIH
All of Us Research Program); (2) evaluate how integrating blood pressure (BP) data from novel
smartwatch-based home BP monitors enhance predictive models for risk stratification in
glaucoma, and (3) measure glaucoma medication adherence using innovative flexible electronic
sensors to validate their use for future interventions aimed at improving adherence and clinical
outcomes in glaucoma.
In this proposal for an administrative supplement, I intend to build upon my existing studies by
continuing to analyze data from the NIH All of Us Researcher Workbench. I will leverage my
extensive experience with All of Us and will conduct research to better understand the
relationships between glaucoma and factors such as social determinants of health, substance
use, wearable/activity data, and genetics. This will expand the impact of my existing research
program, which aims to improve risk stratification and generate novel therapeutic targets for
glaucoma patients.

Public health relevance
PROJECT NARRATIVE A precision medicine approach is critical for early detection and treatment of glaucoma, an insidious chronic eye disease that can lead to blindness and severely decreased quality of life. While I have conducted analyses to examine the relationship between systemic conditions and treatments with glaucoma progression, there is ongoing need to delve into these further by examining factors such as social determinants of health, substance use, and genetic factors. This supplement proposes the expansion of analyses using data from the NIH All of Us Research Program, a diverse nationwide cohort, to enhance understanding of glaucoma pathophysiology and identify new potential therapeutic strategies.